Neutrophil extracellular traps and high-precision MRI measures of tissue injury after intracerebral hemorrhage

PROJECT SUMMARY
Among stroke subtypes, spontaneous intracerebral hemorrhage (ICH) has the highest mortality and disability.
Neutrophilic inflammation is associated with poor outcomes after ICH. However, the mediators of such injury are
unknown. Neutrophils are known to secrete neutrophil extracellular traps (NETs). NETs are complexes of DNA
and proteins, that neutrophils can secrete into the blood as part of an innate immune response. NETs also
facilitate endothelial injury and thrombosis. Previously, NETs have been therapeutically targeted in animal
models in other disease entities. In ICH, edema formation through endothelial disruption and ischemic lesions
through microthrombosis are prime candidates for NET-mediated tissue injury. Both are associated with poor
outcomes. However, the contribution of NETs to edema and ischemic events after ICH has not been investigated.
This proposal seeks to biochemically measure markers of harmful neutrophil inflammation (NETs),
transendothelial tissue migration (soluble intercellular adhesion molecule 1, sICAM-1), and resulting neuronal
injury (neurofilament lightchain, NfL) in blood and cerebrospinal fluid of patients with ICH, and assess local tissue
injury (perihemorrhagic edema, PHE volumes), and remote tissue injury (new ischemic lesions) using an
innovative MRI approach with high spatial resolution and short imaging time. The proposed research will
demonstrate 1) a contribution of NETs to PHE and new ischemic lesions, framed by increased neutrophil tissue
infiltration and resulting neuronal death, and will thereby shed light on this mechanism of neutrophil tissue injury
in ICH, and identify potential treatment targets to prevent secondary injury after ICH, and 2) the feasibility of a
precise MRI sequence that will make PHE measurements a usable study endpoint in future ICH treatment trials.
This proposal will allow the candidate to transition to independence with expertise in biomarker validation, clinical
trial conduct, and implementation of MRI markers as study endpoints in hemorrhagic stroke studies. The
acquired expertise through this proposal will allow the candidate to prospectively study new therapies for ICH
using tissue-based definitions of therapeutic success in addition to conventional outcome measures.
The candidate has the support of an interdisciplinary team led by the co-primary mentors (1) Dr. Ramon Diaz-
Arrastia, an expert in the field of molecular and imaging biomarkers in neurological disease, and (2) Dr. Scott
Kasner, an internationally distinguished stroke trialist. The committed collaborators will provide expertise in the
use of novel MRI measures as study endpoints in studies on ICH (neuroimaging acquisition, analysis, and
interpretation). All mentors and collaborators are committed to the success of the proposed research and to
guiding the candidate in becoming an independent clinician-scientist and expert in the field of secondary injury
with the long-term goal to find therapies directed against neutrophil-mediated tissue injury in patients with ICH.

Public health relevance
PROJECT NARRATIVE A deeper understanding of injury processes in spontaneous intracerebral hemorrhage (ICH), a severe form of hemorrhagic stroke for which there are no effective treatments, is critical. Through serum, plasma, and cerebrospinal fluid measures of maladaptive neutrophil inflammation (neutrophil extracellular traps, NETs), transendothelial neutrophil migration (soluble intercellular adhesion molecule-1), and brain tissue injury (neurofilament light chain, NfL), and by using an innovative high-resolution brain MRI approach in a prospective cohort of patients with ICH, the goal of this proposal is to acquire expertise in biomarker validation, clinical study conduct, and the use of imaging markers as endpoints in clinical trials in patients with ICH. This proposal will identify the contribution of NETs to local (edema) and remote (ischemic lesions) tissue injury, both associated with poor outcome after ICH, which may define novel treatment targets for patients with ICH, at the level of neutrophil migration, activation, or generation of NETs (NETosis).